Nanohydrocyclones for scalable extracellular vesicle purification and drug loading

PROJECT SUMMARY
Next-generation therapeutics based on extracellular vesicles (EVs) as biologically-derived drug carriers have
emerged as a highly promising route to the treatment of a wide range of cardiovascular and respiratory diseases.
Despite the broad interest in EV-based drug development, it is increasingly clear that existing methods for
preparing therapeutic EVs suffer from a number of constraints that present a significant barrier to clinical
translation. In addition to low throughput, long processing times, and labor-intensive operational steps,
established separation methods suffer from poor separation efficiencies that result in vesicle loss, size bias, and
co-elution of soluble proteins that contaminate the resulting nanovesicle drug. This latter challenge is of particular
concern, as the presence of soluble proteins complicates interpretations of efficacy and safety. An additional
issue is that while microRNAs (miRNAs) encapsulated within EVs represent a key component conferring
therapeutic effect, the intrinsic concentration of miRNA in EVs is extremely low. As a result, effective EV therapies
require that exogenous miRNA be loaded into the vesicles to increase potency. While a number of EV cargo
loading techniques have been developed, many of these methods demand to introduction of external electrical
or acoustic energy that can damage the vesicles and their cargo. Furthermore, existing EV separation and
loading techniques require multiple processing steps that are not inherently scalable, increasing development
cost and time, and presenting a practical challenge for moving EV therapeutics beyond the preclinical stage. In
this R21 project, we propose a new scalable approach to EV separation and drug loading that is compatible with
the needs for clinical translation, addressing a significant bottleneck in EV biomanufacturing and enabling a
single-step streamlined workflow for the preparation of high potency EV therapeutics. The proposed technology
consists of a single device integrating efficient size-based EV separation with drug loading into a scalable,
automated, and self-contained process. The platform will leverage a miniature hydrocyclone technology
previously developed by our team that has the potential to isolate EVs in the 30-150 nm range in a passive flow-
through microfluidic chip. An array of hydrocyclones operating at high flow rates on the order of 1 mL/min will be
combined with integrated microfluidic counterflow microdialysis elements to implement a proven pH-gradient-
based loading method developed by our group to control EV cargo encapsulation. The scalable platform will
enable in-line loading of purified EVs from any cell or biofluid source, using a simple workflow expected to
significantly reduce therapeutic EV processing time and cost. The resulting system is further expected to improve
vesicle purity and cargo loading efficiency, supporting the development and translation of a new class of EV
therapeutics with the potential to impact treatment of a broad range of cardiovascular and respiratory diseases.

Public health relevance
PROJECT NARRATIVE Extracellular vesicles (EVs) secreted by cells hold great promise for the treatment of a wide range of cardiovascular and lung diseases. However, current methods to harvest EVs and load them with suitable cargo for therapeutic applications require significant time and effort, limiting their development and practical use in the clinic. This project seeks to overcome this limitation by developing a single-step nanoscale hydrocyclone technology capable of purifying and loading EVs in a single flow-through process.